Diamond Rotors

Project Summary
The research in this proposal focuses on the development of methods for fabricating magic-angle
spinning (MAS) rotors from single crystal diamond logs for applications (1) in ambient temperature MAS
experiments, and (2) dynamic nuclear polarization (DNP) MAS experiments. In particular, there is an ever-
increasing push towards rotors that attain higher spinning frequencies for MAS NMR in order to improve
sensitivity and resolution. However, the spinning frequencies currently obtainable (~100 kHz) are limited by
the strength of the material from which the rotors are fabricated – typically ZrO2 with flexural strength of
~800 MPa. Above ~120 kHz the ZrO2 rotors explode. Diamond is one of the strongest materials on earth
with flexural strengths of 2-5 GPa for single crystal samples and therefore an ideal material to manufacture
MAS rotors. Furthermore, diamond is transparent to terahertz radiation, so it is ideal for DNP experiments.
Finally, it has excellent thermal properties – it thermal conductivity is 10x better than Cu. Thus, it is easy to
compensate for the aerodynamic heating associated with MAS. Machining diamond cylinders to high
tolerance required for rotors requires a novel laser machining processes which we have begun to develop to
produce small (≤1.3 mm OD) diamond rotors. Here we propose to refine our processes and test them in our
available instrumentation. The goal is to produce 1.3 mm, 0.7 mm and a new generation of 0.5 mm rotors
that will attain ωr/2π>300 kHz and improve the resolution of MAS spectra by a factor of ~5 over what is
currently available. In addition, we anticipate that diamond rotors will lead to larger DNP enhancements.
We also describe some applications to amyloid fibrils and membrane proteins where we anticipate that
diamond rotors will have a significant scientific impact.

Public health relevance
Narrative: The research proposes to develop methods to fabricate magic angle spinning (MAS) NMR rotors and drive tips from single crystal diamond samples using laser micromachining techniques. The reasons for using diamond are (1) that it is stronger than other materials such as ZrO2, (2) it is transparent to microwaves and therefore better for DNP experiments, and (3) has excellent thermal conductivity so that samples will cool more efficiently. The higher strength will enable higher spinning rates and better sensitivity will lead to molecular structures with higher precision and could have a profound impact on structural biology, medical imaging and solid state NMR.